PRODUCTION OF HYBRIDOMAS

Hybridomas are being produced which secrete monoclonal antibodies of defined antigen specificity. Hybridomas have been produced against the Fc-epsilon receptor of mast cells and to human IgE. These monoclonal antibodies are being used for biochemical and biological studies.